Determining the Role of Me31B Protein in Germ Cell Development

PROJECT SUMMARY
Germ cells give rise to eggs and sperm, and ultimately to a new organism of the next generation. For many
animal species, germline development and germ cell formation depend on the activity of Me31B/DDX6 family
RNA helicases. These helicases are believed to play critical roles in post-transcriptional RNA regulations to
ensure proper spatial-temporal expression of the RNAs, which eventually leads to germline development.
However, the molecular-level working mechanism of Me31B family proteins remains elusive. To study this, the
PI’s research team proposes to use Drosophila Me31B as a model to address three specific knowledge gaps in
our understanding of this protein: 1) What are the functionally important motifs in the Me31B protein? 2) What
functions do the motifs play, and how do they contribute to Me31B’s role in germline development? 3) How is
me31B expression regulated at the post-transcriptional level in the germline? The PI’s team hypothesizes that
the functional motifs in Me31B play important roles in the protein’s overall activities such as regulating germline
RNA stability, localization, and translation, which leads to proper germline development. To test this
hypothesis, the team plans to: 1) Identify the functionally important motifs in the Me31B protein and generate
novel Drosophila strains mutant for those motifs, 2) characterize the mutations’ phenotypic effects on
Drosophila germline development, and 3) determine the mechanism of how me31B gene expression is
regulated post-transcriptionally. These experiments will help achieve the goal of the proposed research:
understanding Me31B’s in vivo working mechanism and its role in germ cell development. Knowledge obtained
from the Drosophila Me31B model can be used to understand the working mechanism of the protein’s
homologs in other species such as human DDX6 protein. Further, this knowledge will shed light on
Me31B/DDX6’s role in human growth and development, as well as potential treatments for human disorders
related to this gene/protein.

Public health relevance
Project Narrative The proposed research will study the in vivo working mechanism of a Me31B/DDX6 family protein, an evolutionarily conserved RNA helicase important for the development of germ cells and certain soma in diverse animal species including humans. In humans, mutations in this protein cause intellectual disabilities, genitourinary anomalies, and many other developmental delays and defects. Knowledge gained from this research will provide a better understanding of how Me31B/DDX6 family proteins contribute to germ cell development and human growth, and shed light on potential treatments for human disorders related to this gene.